LitCog IV: Health Literacy and Cognitive Function Among Older Adults

ABSTRACT
We request to continue our NIA cohort study (‘LitCog’; R01AG030611). LitCog studies the confluence of
increased medical morbidity resulting in complex patient self-management (SM) roles, and cognitive decline,
which may affect older patients’ health literacy (HL) skills and chronic illness self-care. Functionally independent,
‘cognitively normal’ adults ages 55-74 (N=900) were recruited from community primary care practices in Chicago.
Participants have completed comprehensive cognitive, psychological, social, behavioral, and functional health
assessments every 3 years (4 interviews; 2008-2018). The sample is diverse by race, socioeconomic status and
medical morbidity; uncommon among cognitive aging studies. A 1st renewal award (LitCog II) examined changes
in cognition, HL and SM skills over 6 years and their associations with physical and mental health. We found
cognitive function to be strongly associated with HL; both decline together over time. Cognitive function and HL
also determine older adults’ SM skills; all predict functional health status and its decline. A 2nd renewal (LitCog
III) has allowed us to capture new health behaviors, chronic disease outcomes, and healthcare use from medical,
pharmacy records a decade post-baseline. Cognitive function, HL and SM skills impact all of these outcomes.
LitCog III is almost complete; 774 of 900 (86%) subjects are alive and available for further study.
We now propose to conduct follow-up assessments 12 and 15 years post-baseline (LitCog IV). With 6
interviews over 15 years, specific trajectories of decline in cognition, HL, SM skills and health status can be
closely studied. The prevalence of and adjustment to increasing morbidity, disability, cognitive impairment
(including Alzheimer’s Disease & Related Dementias (ADRD)) allow for new outcomes for investigation. Mortality
data will also now be available with extended follow-up. Our primary aim is to 1) evaluate trajectories in cognitive
function, HL and SM skills over 15 years among older adults, and their associations with health outcomes.
LitCog is an exceptionally unique cognitive aging cohort study as it is framed in the context of health services
research. Our goal has been to inform health system strategies for effectively managing older patients by
understanding how cognition changes and influences HL and SM skills necessary for achieving optimal health.
Modifiable factors that may mediate/moderate associations are also explored as potential intervention targets.
The involvement and roles of caregivers has specifically emerged as an important social determinant of patients’
health. An administrative ADRD supplement (LitCog IIIA) has expanded our inquiry by including interviews with
caregivers (informal or paid) involved in supporting the care of 60% of participants. In LitCog IV, we will create a
parallel caregiver cohort, with the secondary aims to 2) investigate associations between the presence of an
involved caregiver with treatment adherence, chronic disease outcomes, and functional health status among
older adults; 3) identify factors influencing associations between caregiver involvement and patient outcomes.

Public health relevance
PUBLIC HEALTH NARRATIVE As the number of adults over 65 is expected to double by 2050, health systems must urgently seek ways to support the many older adults managing not just one but multiple chronic conditions, while contending with cognitive decline as the result of aging. Our LitCog IV study has the unique ability to elucidate potentially modifiable, causal mechanisms linking cognitive decline and impairment to worse health; with a particular focus on the optimal involvement of caregivers. Findings will directly guide the design of effective health system interventions to support the primary care management of a diverse, older patient population.